Novel Pathways and Therapeutic Targets for Cisplatin-Associated Acute Kidney Injury

PROJECT SUMMARY/ABSTRACT
Cisplatin is a well-known chemotherapy that results in a high incidence of acute kidney injury (AKI),
occurring in up to one in three adults receiving a single dose. Despite efforts to find less toxic but equally
effective alternatives, platin-based therapies are still incorporated in up to 40% of chemotherapy regimens, and
remain first-line treatment for a number of cancers. AKI occurring after oncologic treatments such as cisplatin
is associated with significant morbidity and mortality; it is therefore of paramount importance to identify
effective strategies aimed at prevention of cisplatin-associated AKI (CP-AKI).
In Aim 1, we will examine the effect of 4 medications (Intravenous [IV] magnesium [Mg], mannitol,
metformin, and statins) on the incidence of CP-AKI. We will leverage a unique database of >45,000 adult
patients treated with IV cisplatin at 4 major cancer centers, applying the principles of target trial emulation to
address common biases in observational studies.
In Aim 2, we will build upon animal models showing the protective effects of IV Mg on CP-AKI and our own
preliminary data showing that lower serum Mg levels are independently associated with AKI in cardiac surgery
patients. We will conduct a randomized clinical trial (RCT) in mesothelioma patients receiving hyperthermic
intraoperative chemotherapy with cisplatin (HIOCC) (n=80) comparing IV Mg to placebo for the attenuation of
CP-AKI. We will collect blood and urine samples pre- and postoperatively, comparing changes in serum
creatinine and novel markers of tubular injury between the two groups.
In Aim 3, we will recruit 150 high-risk patients receiving IV cisplatin to examine whether a byproduct of the
nicotinamide adenine dinucleotide (NAD+) pathway, urinary quinolinate normalized to tryptophan, is elevated
in CP-AKI. If so, administration of agents directed at increasing NAD+ metabolites may be a promising
preventative strategy for CP-AKI in future studies.
The projects proposed in this K23 application will provide the training needed to 1) become an expert in
onco-nephrology; 2) apply advanced epidemiologic techniques to observational datasets; 3) develop skills in
prospective patient recruitment; 4) build a biobank; 5) and acquire skills in the conduct of RCTs. The PI has
guidance from mentors Dr. David Leaf, an expert in AKI, RCTs, biomarkers, and onco-nephrology, as well as
Dr. Deborah Schrag, a world-renowned oncologist, outcomes researcher, and clinical trialist. The PI has
assembled an advisory committee of experts in causal inference, Mg homeostasis, statistics, and translational
research. The combination of a world-class mentorship team, a rich scientific environment, and proposed
training will support the PI’s goal to become an independent patient-oriented researcher in onco-nephrology.

Public health relevance
PROJECT NARRATIVE Acute kidney injury (AKI) is a common complication of cisplatin chemotherapy, and effective therapeutic and preventative strategies for cisplatin-associated AKI (CP-AKI) are lacking. In this proposal, we will study the association between intravenous magnesium (IV Mg), mannitol, metformin, and statins and CP-AKI using a target trial framework; we will evaluate in a double-blind, randomized, placebo-controlled trial whether the administration of IV Mg reduces the risk of CP-AKI in patients receiving hyperthermic intraoperative chemotherapy with cisplatin; and we will examine in a prospective cohort study whether urinary quinolinate normalized to tryptophan, a novel marker and potential therapeutic target for AKI in other contexts, is elevated in patients with CP-AKI.